Administrative Core

The Administrative Core will provide logistic, administrative, statistical, and budgetary support
for all projects and cores in the DELTA Center. The core will be directed by Dr. Andrew
Cameron, PI for the overall grant, who will also serve as the Core’s clinical Director. The Core’s
Scientific Director will be Zhaoli Sun, and the Core’s Administrative Director will be Dan Warren.
The core will be responsible for fiscal management of the overall program, and generating
budgetary reports for each of the other projects and Cores, in conjunction with research
administrative personnel and financial managers from the departments of Surgery, Psychiatry,
and Pathology. In addition, the Core will provide clerical support assisting investigators in
preparation of manuscripts, preparation of competing and non‐competing grant renewals, as
well as processing of outside requests for pathology samples from explanted livers from outside
researchers. Perhaps most importantly, the Admin Core will direct the future of the DELTA
Center, specifically cultivating the training of the next generation of clinical and research
leaders for alcoholic hepatitis. The Core will also be responsible for insuring that all
investigators maintain strict compliance with relevant regulatory bodies at Hopkins including
the Animal Care and Use Committee (ACUC), the Institutional Review Board (IRB).
Finally, the Core will broadly support communication and interaction between Program
investigators by coordinating the monthly Steering Committee meeting, including assisting with
travel arrangements and lodging and reimbursement for outside speakers. The Administrative
Core will act as the primary liaison between Program Participants and the Internal and External
Advisory Boards and will schedule and provide logistical support for the Annual Program
Retreat and Advisory Board Meeting.
The Core will be housed in 200 square feet of dedicated administrative space immediately
adjoining the offices of Dr. Andrew Cameron, Dr. Zhaoli Sun, and Dr. Dan Warren.